Geospatial modeling of iAs exposure

ABSTRACT: PROJECT 3
Chronic exposure to inorganic arsenic (iAs) has been linked to risk of type 2 diabetes (T2D) in epidemiologic
studies and a major source of exposure is through unregulated private wells. Yet, there is a significant gap in
methodologies that can be used to predict iAs contamination in untested private wells and determine major
contributing factors (e.g. geogenic versus anthropogenic). Project 3 addresses this research gap and builds upon
a strong scientific foundation. First, the team has developed various datasets that will be key to the study. This
includes a database of the Superfund sites and their associated chemicals in the US and NC, the NCWELL
database of >90, 000 private well measures. Second, we have developed innovative analytical methods that will
be employed including a Bayesian maximum entropy (BME) approach that can be used to predict iAs levels in
untested areas of NC and the Chemical and Social Stressors Integration Technique (CASS-IT) to identify areas
where populations are at risk for elevated exposure to iAs, co-occurring contaminants and social stressors. We
hypothesize that that geospatial models that incorporate geogenic and anthropogenic data, social
vulnerability factors, and disease prevalence can predict locations of populations at risk for iAs-
associated diabetes. To test this hypothesis, we will pursue three aims. In Aim 1, we will use geospatial
modeling techniques to predict iAs levels in untested private drinking wells in NC and determine contribution
from geogenic or anthropogenic point sources. In Aim 2, we will examine whether there are disparities in iAs
levels in NC drinking wells in relation to sociodemographic and geospatial characteristics. In Aim 3 we will use
ecologic analysis to estimate iAs-associated metabolic disease risk and associated economic burden. Our strong
team has complementary expertise in geospatial modeling, environmental science, geology, environmental
justice, and economic estimation. Together we use innovative techniques to characterize contributions of
numerus factors to iAs-associated diabetes risk. Project 3 supports the UNC-SRP theme “Protecting vulnerable
populations from arsenic-induced metabolic dysfunction with a vision for exposure reduction and
disease prevention.” Project 3 is both significant and innovative, as it will use integrated geospatial methods for
the prediction of elevated iAs and the identification of populations at most risk for iAs-induced adverse outcomes
to guide future public health initiatives. By accomplishing this aim, we will enhance the understanding of the
critical factors that contribute to the prediction of iAs levels in private wells, with implications for more than 44.5
million individuals across the US drinking from private wells.

Public health relevance
NARRATIVE: PROJECT 3 The research in Project 3 is relevant to public health protection as it will use geospatial modeling approaches to identify various geogenic and anthropogenic factors that influence inorganic arsenic (iAs) contamination in unregulated private wells. The research will identify North Carolina populations at greatest risk for iAs-induced adverse outcomes to guide future public health initiatives. The research is relevant to the more than 44.5 million individuals across the United States (US) drinking from private wells and at risk for metabolic dysfunction/diabetes.